AGE RELATED MEMORY CHANGES IN KVB11 DEFICIENT MICE

The long-term objective of this project is to elucidate the neuronal mechanisms that underlie age-related deficiencies in learning and memory. Recently, our laboratory has created a strain of mice in which the Kvbeta1.1 subunit of the potassium channel has been deleted. Deletion of the Kvbeta1.1 subunit produced impairments in hippocampus-dependent learning in young Kvbeta1.1 mutants. Remarkably, aged (greater than 18 mo.) Kvbeta1.1 mutants showed no such impairment and do not exhibit the age-related memory deficits normally seen in age-matched wild-type mice. The specific aims of this proposal are to 1. Further characterize the learning behavior of these mice, using a combination of well established behavioral paradigms (i.e. Morris water maze and Pavlovian fear conditioning) and 2. Investigate the neuronal mechanisms that underlie the absence of age-related learning deficits in the aged Kvbeta1.1 mutants. Specifically, electrophysiological experiments will be conducted to explore the possibility that the Kvbeta1.1. mutants might exhibit alterations in neuronal excitability and how these alterations might affect specific forms of synaptic plasticity thought to mediate learning and memory. The proposed research will serve as the basis for improving our understanding of age-related changes in human learning and memory and thereby help in the amelioration of cognitive decline in the elderly.